Organization and development of motor cortical circuits for speech production in stuttering

At its core, stuttering reflects disruption in speech motor control, influenced by cognitive, affective, and sensory
factors that modulate the frequency and severity of speech disfluencies in individual speakers. Motor cortical
circuit function and anatomy have been a focus of investigation relevant to the neural bases of stuttering,
however our understanding of structure and functional differences in key motor cortical structures and their
connections with other cortical and subcortical areas remain lacking. This, as well as a lack of studies to date
to link brain-behavior relationships on an individual level, have hampered progress in understanding the neural
bases of this complex disorder and hindered progress toward treatment development. The studies proposed in
this application represent a substantive departure from the status quo by applying a novel integrative motor
cortex anatomical framework to provide a mechanistic, functional neuroanatomical understanding of where and
how breakdowns may occur in stuttering. Three newly discovered “inter-effector” areas (IEAs) that are
interspersed between effector-specific areas along the primary motor cortex were shown to display distinct
morphology and greater connectivity (relative to effector specific regions) to brain regions involved in cognitive
control, sensory input processing, and movement intention. The IEAs likely support critical integrative functions
for complex human actions, with particular relevance for speech production (and speech motor pathology like
stuttering), since speech is the most complex and complexly integrative motor behavior that humans perform.
Among the IEAs, the middle and inferior IEAs support integrative functions relevant to speech control. The
proposed studies aim to examine morphology and functional connectivity of these two IEAs that will contribute
to a fundamental shift in understanding the structure and function of key motor cortical regions and related
circuits that support fluent speech production and areas of breakdown associated with stuttering. In aim 1,
precision MRI mapping will be applied for the first time in this clinical population, expected to reveal critical new
insights on individual-specific variations that are linked to behavioral heterogeneity associated with stuttering.
In aim 2, activity and functional connectivity patterns of the IEAs will be examined during ecologically valid
continuous speech tasks, and aim 3 will examine potential deviations in specific nodes and connectivity
patterns of the IEAs during a developmentally sensitive period for speech and language acquisition. The
proposed studies are completely novel directions that are expected to derive information that could shift the
paradigm in conceptualizing the neural bases and intervention for stuttering. This new knowledge is significant,
because it will help identify specific, individualized targets for future treatment development and preventative
interventions that were unavailable before. Ultimately, the results from this research will have a potentially
broad impact, leading to a better understanding of neural bases of speech motor control and development.

Public health relevance
Stuttering is a speech motor disorder with variable severity manifestations affected by cognitive, affective, and other higher order functions. This study represents the first attempt to investigate the structure and function of the speech-relevant integrative motor regions (“inter-effector areas”) to deeply characterize and identify individual-specific brain-behavior linkages in stuttering. Successful achievement of the proposed aims will be a crucial first step toward future development of individually targeted effective intervention for a disorder that currently lacks efficacious treatments.